Quantitative Imaging Biomarker Prospective Validation of Dynamic Contrast-Enhanced MRI as a Metric of Orodental Injury After Radiotherapy (QI-ProVE-MRI)

PROJECT SUMMARY
The rise in human papillomavirus (HPV)-associated head and neck squamous cell carcinoma (HNSCC) has
resulted in a rapidly increasing number of younger and healthier patients being treated with locoregional radiation
therapy (RT). Although effective in curing the cancer, deleterious RT effects upon organs-at-risk (OARs) such
as the salivary glands, swallowing/masticatory muscles, and mandibular bone can result in lifelong
sequelae of RT normal tissue injury such as xerostomia, dysphagia, and osteoradionecrosis (ORN),
respectively. These long-term sequelae in a patient population with good clinical outcomes and extended life
expectancy are increasingly relevant as latent sources of morbidity and mortality in cancer survivorship. Despite
this urgency, a standardized staging and monitoring system to identify patients at risk for developing ORN and
other morbidities, and to assess the effectiveness of interventional therapies, is not currently available.
At our institution, dynamic contrast-enhanced magnetic resonance imaging (DCE-MRI) is being
integrated into a multimodality clinical algorithm aimed at improving diagnosis, staging, and surveillance of
disease and toxicity. DCE-MRI can detect altered bone vascularity associated with bone healing, necrosis, and
metastatic involvement, with excellent spatial resolution. Based on our previous NIH-funded research, we
hypothesize that an increase in DCE-MRI parameters (i.e., Ktrans/Ve) at any timepoint more than 3 months
after RT demonstrates increased risk of normal tissue treatment-related toxicity rates. Our objective is to
conduct a biomarker analytic and clinical validation study designed to confirm DCE-MRI parameters as
quantitative imaging biomarkers, with the formal deliverable of an application for FDA Biomarker Qualification at
study completion, via the following specific aims: 1) Prospective qualification and validation of DCE-MRI Ktrans/Ve
as an “FDA BEST-defined” quantitative imaging monitoring biomarker of ORN risk; 2) Investigation of DCE-MRI
candidate biomarkers for pre-qualification as quantitative imaging biomarkers of soft-tissue structures; 3)
Standardization of image acquisition and open source computational/analytic software for orodental DCE-MRI
as a potential component of FDA biomarker qualification.
Successful completion of this proposal has the potential to revolutionize the diagnosis and management
of late RT-induced morbidities and offer clinicians a reliable and FDA Biomarker Qualification Program
validated biomarker to stratify patients at risk for OARs injury after RT, monitor bone and soft tissue injury and
subsequent oral morbidity, and manage post-RT care appropriately. This work is particularly relevant to NIDCR’s
mission of “advancing fundamental knowledge about dental, oral, and craniofacial health and disease and
translate these findings into prevention, early detection, and treatment strategies that improve overall health for
all individuals and communities across the lifespan”.

Public health relevance
PROJECT NARRATIVE The proposed clinical research aims to validate the use of dynamic contrast-enhanced magnetic resonance imaging (DCE-MRI) parameters as FDA BEST-defined monitoring biomarkers to monitor the natural history of radiation-associated bone and soft tissue injury and subsequent long-term oral morbidity due to radiation- associated damage (e.g., dry mouth, swallowing difficulty, and jawbone injury/fracture). The work is relevant to public health because of (1) the epidemic rise in HPV-associated oral malignancies, and because this represents (2) the development of the first FDA BEST-defined monitoring biomarker of any kind for oral sequelae of cancer therapy, generally, and the first-ever validated FDA BEST-defined monitoring imaging biomarker of any dental disease process. The innovative research described in this proposal can drive significant change in clinical practice for head and neck cancer by improving survivorship through normal tissue sparing and prevention of long-term toxicity, while maintaining excellent disease control, which always represents a major healthcare challenge.